Patient-Centered Neurological Evaluation of Functional MRI Outcomes in Multiple Sclerosis

Abstract:
Multiple sclerosis (MS) is a chronic inflammatory demyelinating disease with over 1 million individuals affected
in the US; early diagnosis and effective treatment are thus critical to protect quality of life. MS diagnosis follows
from lesions disseminated in time and space, including lesions in the spinal cord (SC). While SC lesions are
associated with a higher rate of relapse, the association between neurological symptoms and progression with
SC damage has been underexplored due to the challenges of imaging the SC. Functional MRI (fMRI) can
uniquely probe SC function in the resting-state and relies on blood oxygenation level-dependent contrast to link
neuronal activity with hemodynamic processes which, when spatially correlated, is a measure of functional
connectivity (FC). Prior SC resting-state fMRI (rs-fMRI) showed ventral-ventral (motor) and dorsal-dorsal
(sensory) gray matter FC at 7T using seed-based analyses, and that lesions can influence FC in patients with
relapsing-remitting MS (pwRRMS). At 3T, diffusion-derived indices of microstructural damage were associated
with FC, suggesting structural-functional interdependence. However, clinically relevant data-driven rs-fMRI FC
signatures have not been explored in depth at 3T, nor their relationship with neurologic deficits. Evaluating data-
driven rs-fMRI FC in the SC of pwRRMS and identifying associations with sensorimotor impairment may provide
an objective evaluator of pathology in the MS SC, beyond what can be explained by structural (clinical) MRI or
neurological evaluation alone. We hypothesize rs-fMRI SC FC is an objective surrogate for neurologic
symptomatology, and that alterations in FC can be related to macrostructural (lesions), microstructural (diffusion),
and/or vascular hallmarks (susceptibility). Unique to this proposal, we will apply rs-fMRI SC FC as a quantifiable
measure to assess motor and sensory integrity of the cervical SC and investigate the complex interactions
between disease deficits and SC rs-fMRI using ROI- and data-driven analyses (Aim 1). We will then evaluate
how microstructural integrity influences observed FC using novel approaches such as tractography and
lesionometry (Aim 2). Finally, vascular hallmarks, such as the central vein sign and paramagnetic rim lesions,
have been identified in the MS cord by our group. We will utilize SC susceptibility imaging at 7T in the same
cohorts to investigate whether these vascular hallmarks are related to altered FC measured at lower field (Aim
3). The clinical impact of this proposal is to evaluate rs-fMRI as a marker of neurologic impairment, in the same
manner that fMRI has been utilized to predict surgical (non)responders in refractory temporal lobe epilepsy. From
this proposal, we may better understand the impact of a devastating neurologic disease and empower patients
with MS. This proposed fellowship will provide research training in a collaborative research atmosphere, with
expert mentors in neuroimaging at a top-tier academic medical center and imaging institute uniquely suited to all
aspects of this work. My training will further develop my resources and knowledge to become a physician-
scientist focused on clinical investigation of cutting-edge imaging methods.

Public health relevance
Project Narrative: Multiple sclerosis (MS) is the most common central nervous system disease affecting young adults, with significant gaps in spinal cord (SC) imaging necessitating advanced techniques like functional MRI (fMRI) to better characterize MS pathology and clinical status. This study will apply resting-state SC fMRI as an objective, quantifiable measure to assess motor and sensory function of the cervical SC in relapsing-remitting MS, and how these neuronal circuits are associated with alterations in SC structural and vascular integrity. Resting-state fMRI signatures arising in the MS SC are the only non-invasive evaluators of SC function, and the relationship between resting state fMRI and neurological outcomes can provide a better understanding of the human experience of MS.